Human Subjects Clinical Core Component 2

PROJECT SUMMARY
The Clinical Core is an ideally-situated brain injury research hub, with state-of-the-science neuropsychological,
electrophysiological and neuroimaging instrumentation to measure brain injury function and novel
neurostimulation technologies for studies of brain injury recovery and repair. The Clinical Core is a
collaborative, interdisciplinary environment providing expert guidance in research design and methods, critical
support for patient recruitment, data collection and management to ensure reliability and reproducibility of
results, and assistance with regulatory compliance using Good Clinical Practices. Collectively, this platform has
unleashed the brain injury research potential at UNM to improve the outcomes of individuals with brain injuries.
The Clinical Core has succeeded in propelling our young, promising investigators to independent research
funding status and is now established as a national leader in research applying innovative neuromodulation
approaches to therapeutically target and alter specific neural circuitries in individuals with neurological
conditions. Overall, the goal of the Core in Phase II is to build on our Phase I accomplishments and continue
our progress towards becoming a self-sustaining research enterprise that is independent of IDeA funding. We
will continue to provide the resources and expertise to support innovative research that will accelerate a new
cohort of Project Leads to independent funding and expand our mass of new and established clinical
investigators as Core users on a fee for service basis. The Core will continue to invest in new instrumentation,
advance our recruiting approaches and ensure tracking and reporting to Human Subjects System (HSS) and
Clinical Trials.gov. The Clinical Core will continue to foster multidisciplinary collaboration between clinical and
preclinical investigators within UNM and reach out to state and regional institutions to develop new
partnerships and training collaborations as we seek to be a leading resource center for brain research.
Through these efforts we will search for new interventions for brain and behavioral illnesses that will lead to
improved outcomes for individuals with brain injury and their families.

Public health relevance
PROJECT NARRATIVE The Clinical Core supports the goals of the Center for Brain Recovery and Repair by providing an essential resource to support studies with human subjects. The Clinical Core serves as a centrally-located Human Subjects research hub that provides expert consultation, mentoring/training, cutting-edge instrumentation and technical support for Project Leads and other clinical neuroscience investigators. These efforts will advance inventions and treatments that will reduce disabilities and improve outcomes for brain injury survivors and their families.